Corticolimbic Neuroimmune Determinants of Social Stress-Associated Alcohol Drinking

PROJECT SUMMARY
Social stress is a prevailing factor in the lives of all social species and can motivate the misuse of reinforcing
drugs such as alcohol. Individuals that use alcohol to alleviate the negative emotions created by social stress
are more likely to develop pathological drinking patterns, which can lead to an alcohol use disorder (AUD).
Indeed, an individual’s standing in a social hierarchy (i.e. social rank) is inversely related to alcohol
consumption in rodents and non-human primates as well as problematic drinking in humans, highlighting the
conserved impact of subordination stress on motivation for alcohol. Social rank also influences how individuals
respond to challenges, and social isolation is a particularly profound stressor with increasing human relevance.
Our data identify a previously unknown relationship between mouse social rank and isolation-associated
escalated alcohol drinking, where subordinates display a greater magnitude increase in drinking following
social isolation compared to dominants. These data suggest that low social rank may be a potent risk factor for
developing pathological alcohol drinking patterns. In addition, our data show a critical role of the amygdala-
cortical circuit in social isolation-induced escalated alcohol drinking. Notably, it is becoming increasingly
evident that social stress induces microglia-mediated neuroimmune responses in select stress-responsive
brain regions, including the basolateral amygdala (BLA) and medial prefrontal cortex (mPFC), which contribute
to stress-induced behavioral adaptations. Indeed, social isolation-induced escalation of alcohol strongly
parallels increases in microglia previously seen following social stress, supporting a potential role for microglia
in isolation-induced adaptations in alcohol drinking. Despite the substantial evidence linking social stress and
alcohol drinking as well as the impact of social stress on neuroimmune signaling, virtually nothing is known
regarding the neuroimmune regulation of circuits underlying social stress-induced behavioral adaptions in
alcohol drinking. This supplement will fill this gap by (1) determining if BLA and mPFC glial activation is
predictive of social rank and isolation-associated alcohol drinking and (2) determining if individual differences in
social anxiety underlie social rank and isolation-associated alcohol drinking. The findings will provide insight
into the role of immune signaling and motivational differences underlying social rank and isolation-associated
alcohol drinking to further support the overarching goal of the parent grant. In addition, this award provides an
opportunity for the candidate, who belongs to multiple underrepresented groups in biomedical science, to gain
new training in fundamental neuroscience techniques, foundational knowledge on addiction neuroscience, and
professional development skills in a vibrant scientific environment under the mentorship of a NIAAA-funded PI.
Ultimately, the findings generated with the support of this award will serve as a foundation for a first-author
body of work for presentation at scientific meetings and a peer-reviewed publication to facilitate a successful
transition of the candidate into a neuroscience PhD program – enhancing diversity in our scientific community.

Public health relevance
PROJECT NARRATIVE Human socioeconomic status is one of the strongest predictors of health and mortality, however little is known regarding the neurobiological mechanisms predisposing individuals of low social status to neuropsychiatric disorders such as alcohol use disorder. This proposal will determine if social anxiety underlies social rank and social isolation-associated alcohol drinking and if amygdala or cortical glial activation is predictive of this behavior. The findings will advance our conceptual framework for neuroimmune regulation of circuits and behavioral factors underlying social rank and isolation-associated alcohol drinking.